Role of chemokines in neuronal function and survival

SUMMARY OF PROPOSAL
Modern antiretroviral therapies have transformed Human Immunodeficiency Virus (HIV) infection into a
chronically manageable disease. However, a significant amount of people with HIV on antiretroviral therapies
present with a spectrum of neurological symptoms. These HIV-associated neurocognitive disorders (HAND)
remain an important aspect of modern HIV pathology, prognosis, and clinical management, raising the need
for the discovery of adjuvant therapies. Clinical evidence also suggests that HAND can be aggravated by
substance abuse, including opioids, which is highly prevalent in people with HIV. Understanding how opioid
use contributes to cognitive impairment in HAND will help identify new approaches and drug targets to treat
HAND in opioid users.
For the past two decades, we have investigated how HIV neurotoxins and opioids contribute to HAND by
regulating the chemokine receptor CXCR4 in the central nervous system. We have demonstrated that proper
CXCR4 signaling via its natural ligand (the chemokine CXCL12) is not only neuroprotective, but it can also
rescue structural (i.e. dendritic spines loss) and functional (i.e. cognitive flexibility) deficits in an animal model
of HAND. Further, we discovered that this pathway is hijacked by viral proteins and inhibited by µ-opioid
receptor agonists, which revealed a new mechanism whereby opioid use can aggravate HAND. Overall, our
body of work demonstrates that the CXCL12/CXCR4 axis is tightly integrated into homeostatic and plasticity
processes in cortical neurons, and disruption of CXCR4 signaling via HIV proteins, inflammatory mediators,
and opioids is an important component of HAND.
For the next (and last) period of this award, we plan
to capitalize on this knowledge and other recent
findings and fill key gaps in the field that will help us
assess the therapeutic value of these discoveries.
Thanks to new collaborations, we shifted our focus
from molecular mechanisms to network level
function – with a main interest in the role of cortical
interneurons in HAND. Notably, cortical
interneurons dysfunction has emerged as a key
factor in neuropsychiatric conditions linked to
substance use disorders.
Our objectives for the next five years are to determine how interneurons contribute to CXCL12’s regulation of
neuronal network activity and cognition in models of HAND, and if the chemokine’s effects are inhibited by
morphine via local circuit modulation. Studies in Aim 1 will examine synaptic plasticity deficits that are
indicative of microcircuit dysfunction in the medial PFC of WT and HIV-tg rats, and if these network-level
deficits are reversed by CXCL12 treatment. Aim 2 studies will examine how dendritic-targeting cortical
interneurons that express CXCR4 (namely, SST+ inhibitory neurons) modulate the activity of local networks
to enhance neuronal connectivity, and how these processes are affected by inhibitory neurons that express
µ-opioid receptors. In Aim 3, we will examine CXCL12/morphine effects in the human brain as a premise to
development of new network-based treatments for HAND.
As this project aims to understand CXCR4 action at the system level, we will utilize experimental methods
that most recapitulate the natural environment of neuronal networks. These include cortical organotypic
cultures, where the three-dimensional architecture of the tissue is preserved and in vivo studies to measure
cognitive flexibility, coupled to ex vivo analyses, as described in detail in the attached proposal.
Based on unexpected new findings concerning CXCR4 expression in mature individual neurons, we
hypothesize that CXCL12 action relies on microcircuit mechanisms that regulates both synaptic plasticity and
cognition. Our working hypothesis is that CXCL12 signaling primes CXCR4+ somatostatin expressing
interneurons in microcircuits to optimally respond to different stimuli and improves network connectivity.
Conversely, morphine acts on larger contingent of interneurons, including CXCR4+ interneurons, ultimately
causing local networks to scale back synaptic connections.
This project will reveal the role of cortical interneurons in cognitive deficits in HAND and test new concepts in
the chemokine/opioid relationship (i.e. not limited to cell autonomous mechanisms) that have a broad range
of consequences for substance use disorders.

Public health relevance
Although combination antiretroviral therapy (cART) has indisputably produced great benefits to the health and well being of HIV-infected patients, HIV-associated neurocognitive disorders (HAND) are still un-treatable and are becoming more common as the HIV+ population on cART ages. In pursuit of a novel approach for HAND therapy, our group has identified a chemokine protein that reverses damage of neuronal micro-architecture caused by neurotoxic HIV proteins, and may revert cognitive impairment. Expanding on these promising studies, we are proposing to determine the mechanisms by which neuronal architecture is restored by the chemokine, which is expected to produce new drug targets for HAND, and will provide novel insights into the neurobiology of learning and memory that will likely translate to other neurological disorders.